Anatomical Changes in Tau Transgenic Models

DESCRIPTION (provided by applicant): Neurofibrillary tangles are one of the primary hallmarks of Alzheimer disease, and closely correlate with clinical severity. They consist of hyperphosphorylated tau that aggregates in the neuronal cell body. Cross sectional histological studies suggest that tangles kill neurons. Tau disaggregation is thus a major target of the pharmaceutical industry, with at least one drug already in human clinical trials. However, recent data suggest that tangles may not be toxic. We propose to test an alternative hypothesis, in which soluble tau induced toxicity leads to activation of apoptosis related cascades, followed by tangle formation. In order to test this model, we have developed in vivo multiphoton based longitudinal imaging techniques for tangles, caspase activation, and propidium iodide (a marker of loss of membrane integrity). Aim 1 applies this approach to Tg4510 P301L tau mice that develop NFT and neuronal loss. Surprisingly, we see caspase activation that appears to precede and predict tangle formation. We will also use array tomography, an advanced microscopic method using ultrathin sections of tissue, to determine the characteristics of the caspase positive, tangle negative cells to test the hypothesis that kinase activation leads to phosphorylation of tau, and that caspase activation leads to the truncation of tau -the combination of which causes tau aggregation into a tangle. We will use gene transfer and pharmacological studies to further dissect this pathway, to ask whether caspase activation, and caspase truncation of tau, are necessary or sufficient to cause tangle formation, neuronal distress or death. Aim 2 asks if NFT remain in viable cells and are long lived, or if they are toxic to the neurons in which they are found either in terms of structure or function. These experiments take advantage of the power of longitudinal in vivo multiphoton imaging to follow the fate of individual tangle bearing neurons for weeks to months. We will also test the hypothesis that tangle bearing neurons are excluded from participation in normal neural system activation from physiological stimuli by exposing animals to an enriched environment, then examining individual neurons in hippocampal subfields for immediate early gene (Arc) expression and the presence or absence of tangles. Aim 3 will rigorously test the hypothesis that wild type, nonmutant tau, undergoes similar phenomenon and that the toxic effects of tau over expression are due, in large part, to soluble tau. We take advantage of 3 models: examination of an alternative transgenic model, the hTau mice which express a minigene of wild type human tau (on a tau null background), introduction of wild type tau (or truncated forms of tau) into wild type mice using gene transfer approaches with AAV2 gene vectors, and the Tg4510 mice, which harbor a tet-response element driving the tau gene. These models allow comparison of wild type and mutant tau, and will also allow us to distinguish te effects of soluble tau from those of misfolded or aggregated tau. Taken together, our proposed studies will test the hypotheses that a non-tangle related mechanism of tau toxicity initiates apoptotic cascades, and that tangles may be a relatively nontoxic, long lived species. The results will have direct impact on design of therapeutic agents destined for clinical trials.

Public health relevance
PUBLIC HEALTH RELEVANCE: Neurofibrillary tangles are widely believed to be the cause of neuronal death in Alzheimer disease, and so the cause of the dementia symptoms that mark this common and devastating disease. The current application will examine the molecular and temporal relationships between neurofibrillary tangles, neuronal death and neuronal dysfunction using advanced microscopy methods and model systems. Based on these results, therapies aimed at reducing the damage done by neurofibrillary tangles will be explored, in an attempt to better understand what causes the damage and how to prevent it. Project Narrative Neurofibrillary tangles are widely believed to be the cause of neuronal death in Alzheimer disease, and so the cause of the dementia symptoms that mark this common and devastating disease. The current application will examine the molecular and temporal relationships between neurofibrillary tangles, neuronal death and neuronal dysfunction using advanced microscopy methods and model systems. Based on these results, therapies aimed at reducing the damage done by neurofibrillary tangles will be explored, in an attempt to better understand what causes the damage and how to prevent it. __SpecificAimsTextDelimiter__ Anatomical Changes in Tau Transgenic Models Do neurofibrillary tangles kill neurons? The classical view is that tau becomes phosphorylated, aggegates into tangles, and neurons die. Based on this model, tau phophorylation and aggregation are leading therapeutic targets, with drugs already entering phase II human trials. But if misfolded soluble tau species are toxic, and tangles are protective or neutral, anti-tau aggregation strategies may miss their intended target. Our current studies suggest that there is most likely a non-tangle related mechanism of tau toxicity that initiates apoptotic cascades. We have developed techniques to directly test this hypothesis in vivo. Specific Aims: Hypothesis 1: Early neuronal dysfunction precedes tau-induced tangle formation. Rationale and approach: Our preliminary data show that caspase activation precedes and predicts neurons that will develop tangles in the next 24 hours, suggesting that a soluble tau related toxicity precedes fibrillar tau. We will use in vivo longitudinal multiphoton imaging of a P301L tau transgenic mouse model (rTg4510) to examine the time course and consequences of caspase activation and tangle formation. Array tomography, an advanced microscopy technique that allows for repeated interrogation of tissue sections, will be used to study the properties of neurons containing soluble or fibrillar tau. Pharmacological and gene transfer approaches will be used to study the role of caspase cleavage in tau induced neuronal dysfunction. Specific aim 1A. Test the hypothesis that caspase activation and tau cleavage occur in neurons preceding generation of Thioflavine S+ tangles. Specific Aim 1B. Test the hypothesis that neurons that are caspase positive but thioflavine S negative will show mitochondrial mistrafficking, and phosphorylation and truncation of tau. Specific Aim 1C. Test the hypothesis that blockade of caspase activation, introducing tau with a mutation at the caspase site, or introduction of truncated tau mimicking caspase cleavage, will prevent or induce NFT formation. Hypothesis 2: Persistence of tangles is associated with prolonged survival but continued morphological and functional defects Rationale and approach: Neurons overexpressing tau appear to undergo caspase activation early in the life history of a tangle - but most tangles seem to be long lived. In vivo longitudinal imaging will help us answer the question: Do tangle bearing neurons recover? Analysis of immediate early gene expression after environmental enrichment will help answer the question: Are they functionally active? Specific aim 2A. Test the hypothesis that neurons that become caspase positive develop long lived NFT or die. Specific aim 2B. Test the hypothesis that neurons that contain NFT are less responsive to environmental stimuli than neurons that do not contain NFT. Hypothesis 3: Tau P301L and wild type tau produce similar defects in structure and function, which are due at least in part to soluble tau species. Rationale and approach: In FTD, P301L tau induces neurodegeneration characterized by NFTs and neuronal loss, whereas in AD, nonmutant tau is associated with the same types of lesions. We will utilize both the Tg4510 (P301L) mice, which harbor a dox response transgene, and the htau mice, which express a wild type human minigene, to compare the kinetics and characteristics of these models directly. Additionally, we will be able to suppress soluble forms of tau can be reduced by suppressing the transgene even after tangles form in the Tg4510 mice, to help distinguish between the effects of soluble tau and aggregated tau Specific aim 3A. Test the hypothesis that reduction of soluble tau, by turning off the transgene (with doxycycline), will decrease caspase activation, rescue mitochondrial mistrafficking, but not diminish the number of NFT. Specific aim 3B. Test the hypothesis that htau mice, overexpressing wild type human tau, develop the same neurobiological phenotype as observed in tg4510 P301L tau mice.